The National Center for In-situ Tomographic Ultramicroscopy (NCITU) Supplement

Project Summary/Abstract
The National Center for In-situ Tomographic Ultramicroscopy (NCITU) seeks
supplemental funding to acquire dedicated access to cryo-fluorescence microscopy
capabilities. Currently, NCITU shares access to a Zeiss Airyscan cryo-light microscope
within the Simons Electron Microscopy Center (SEMC), but with the recent expansion of
focused ion beam (FIB) microscopes at the center, dedicated instrumentation has
become essential to meet growing user demand. The requested supplemental funding
will support dedicated access to a Leica Stellaris 8 cryo-fluorescence confocal
microscope, which offers critical advanced capabilities beyond what is available through
our current shared instrumentation.
The Leica Stellaris 8 system provides superior flexibility in fluorophore selection and
allows optimized detection thanks to the ability to measure the full spectra. This capability
becomes crucial when imaging weak markers in vitrified samples, and it allows complete
freedom in selecting markers appropriate for their specific biological questions. Notably,
the Stellaris 8 can measure fluorescence lifetime, enabling sophisticated multicolor
imaging, which reaches up to 11 simultaneous colors on this platform at room
temperature. This expanded multicolor capability will open the possibility of investigating
complex processes by simultaneously tracking multiple subcellular markers with precise
spatial and temporal correlation.
This enhanced cryo-fluorescence microscopy capability will directly support NCITU's
mission of providing cutting-edge in-situ structural biology services and training to
researchers nationwide. With established infrastructure, experienced staff, and a growing
user base across 16 states, NCITU is ideally positioned to maximize the impact of this
investment. The primary objectives of this supplement are to ensure NIH-funded
researchers have access to the most advanced correlative microscopy techniques and to
eliminate scheduling bottlenecks that currently limit throughput. This expansion will
accelerate biomedical discoveries across multiple fields by enabling researchers to
precisely correlate multiple cellular components in space and time before visualization by
cryo-electron tomography.

Public health relevance
Project Narrative The National Center for In-situ Tomographic Ultramicroscopy (NCITU) at NYSBC currently shares access to cryo-fluorescence microscopy capabilities but requires dedicated access to advanced instrumentation to support the growing number of focused ion beam microscopes and user demand. The requested supplemental funding will secure dedicated access to a Leica Stellaris 8 cryo-fluorescence confocal microscope with full-spectrum detection and fluorescence lifetime measurement capabilities, enabling researchers to simultaneously track multiple cellular markers with unprecedented precision in both space and time. This enhanced correlative microscopy capability will significantly accelerate in-situ structural biology research nationwide by removing current throughput limitations and providing researchers with the most advanced tools to target specific subcellular structures and events for high-resolution imaging by cryo-electron tomography.